PORT (Portland Oral health Research Training)

The Portland Oral Health Research Training (PORT) Program is a comprehensive research-training program
built on our successful history of research training and mentoring at the Oregon Health & Science University
School of Dentistry (OHSU SOD). This program is leveraged on our creative, collaborative and collegial basic
and translational research scientists using innovative, integrated, and interdisciplinary approaches to address
the critical issues in oral health research and research workforce needs facing our nation. This new application
is bolstered by several important aspects, including our recent experience with a new DMD/PhD program, our
strong NIDCR support in microbial sciences, biomaterials/tissue engineering/regenerative medicine, and clinical
and translational research, which includes prestigious R35 awards to two outstanding mid-career investigators
within the SOD, an active campus-wide research training environment supported by dozens of NIH funded
training grants, and a large pool of research-experienced undergraduates from partner institutions, Portland
State University and Oregon State University, housed in the same new research and education building as the
OHSU SOD. The experience accumulated from these scholarly activities and partnerships across Oregon has
led to this innovative program designed to enhance the interests and knowledge of dual degree students,
graduate students, and postdoctoral fellows and visiting foreign-trained dentists, in basic, translational and
clinical research. The PORT creates a structured path forward to productive, independent academic oral health
research careers. Integrative school-based, university-wide core PORT scholarly activities, and across campus
ongoing academic events, including the SOD’s Dean’s Seminar Series, OHSU Research Week, Pre-matriculation DMD Students’ Research Fellowship, Student Research Group seminars and events, Fellowship
for diversity in undergraduate and postdoctoral research, and courses in Mentorship, Scientific and Grant Writing,
Public Speaking and Presentation Workshop, and Leadership Training Opportunities, are key to the PORT
training experience The 5-year PORT Program offers four complementary training paths to maximize its
effectiveness: Track I - DMD/PhD with one position requested in year 1 and another position required from year
2 on; Track II - Pre-doctoral Ph.D. with one position throughout the funding cycle; Track III - Post-doctoral training
with two emphasis subtracks: A) a traditional post-doctoral experience, and B) a Master’s of Science degree in
Clinical & Translational Research, three positions requested for year 1, and 4 positions for year 2 on; and Track
IV - Pre-doctoral Ph.D. or Postdoctoral training for foreign-trained dentists with one position in Year 1, and an
additional position added from Year 2 on. The PORT is intended to accelerate the transition of highly motivated
qualified candidates into independent oral health researchers in a collegial, diverse and inclusive academic
environment.

Public health relevance
The OHSU SOD is uniquely positioned to offer this comprehensive research mentoring and training PORT for the next generation of oral health scientists since we are the only dental school in the state of Oregon, supported by robust OHSU and state-wide research and research training resources. We are committed to address current and future shortages in the oral health research workforce by preparing a diverse and inclusive cadre of individuals for careers as independent scientists. Our objective is consistent with NIDCR’s mission to advance national research needs in the dental, oral and craniofacial health and science.